CCR-Frederick Flow Cytometry Core

To date in FY2022, the Core has performed 236 billable services, including 432 individual samples sorted and 1023 hours billed. The core's cytometers were used for 1573 sessions totaling more than 4300 hours. The Core recorded 99 individual users from numerous CCR programs including the Cancer Innovation Laboratory, Mouse Cancer Genetics Program, Chemical Biology Laboratory, RNA Biology Laboratory, Cancer & Developmental Biology Laboratory, Center for Structural Biology, and Laboratory of Cell & Developmental Signaling. The core also provided services for the Collaborative Clinical Research Branch (NIAID), the Office of Scientific Operations, and the FNL Molecular Characterization Lab. The core trained 28 new users (scientists, fellows, students and technicians) from 7 different labs to use flow cytometry in their work. To keep up with evolving cytometry technology and ensure uninterrupted service as old instruments are declared obsolete by vendors, core staff evaluates new instruments and software, and meets regularly with flow facility leaders across NCI to harmonize instrument offerings and secure favorable pricing for equipment and service maintenance agreements. Recent live evaluations include the Miltenyi Tyto microfluidic sorter (Oct 2021), Thermo Bigfoot cell sorter (May 2022), and BDBiosciences FACSplore spectral & imaging cytometer (Jul 2022). The core added 96 and 384-well sampling capabilities to an additional instrument (May 2022); with 3 instruments now configured for high throughput analysis, investigators may screen large libraries for antibody discovery. The core also built bespoke hardware for depositing sorted cells in Terasaki microwells for hematopoietic progenitor single cell cloning (Jun 2022). The Core presented a technical poster describing data spill-spread phenomena in multicolor cytometry at the USAMRDC Spring Research Festival, April 2022. The core was acknowledged for technical contributions to these 2021/2022 publications: 1) ID2 and HIF-1a collaborate to protect quiescent hematopoietic stem cells from activation, differentiation, and exhaustion. Jakubison BL et al. J Clin Invest 2022 132(13): e152599. PMID: 35775482, 2) Alpha synuclein, the culprit in Parkinson disease, is required for normal immune function. Alam Md et al. Cell Reports 2022 38:110090. PMID: 35021075, 3) Coumarins to Cyanines: Synthesis of Hemicyanines. Caldwell DR et al. Org. Lett 2021 23:8857. PMID: 34752112, 4) Targeted Fluorgenic Cyanine Carbamates Enable In Vivo Analysis of Antibody-Drug Conjugate Linker Chemistry. Usama SM et al. J Am Chem Soc 2021 143:21667. PMID: 34928588, 5) Cyanine Masking: A Strategy to Test Functional Group Effects on Antibody Conjugate Targeting. Thapaliya ER et al. Bioconjugate Chem 2022 33:718. PMID: 35389618, 6) An optimized bicistronic chimeric antigen receptor against GPC2 or CD276 overcomes heterogeneous expression in neuroblastoma. Tian M et al. J Clin Invest 2022 In press, PMID: 35852863.